Transportation, air quality, and health: a community-centered study of road pricing in Washington, DC.

SUMMARY – RESEARCH PROJECT 1: Transportation, air quality, and health: a community-centered study of road pricing in Washington, DC
On-road vehicle emissions are the top contributor to air pollution-related health burdens in Washington,
District of Columbia, where they are associated with over 50% of NO2-attributable asthma cases and
23% of air pollution-attributable premature deaths. As in other cities, these health burdens are
distributed heterogeneously. District leaders are pursuing policies to address these issues. Road pricing
(alternatively called congestion pricing) is a policy being considered in cities around the world as a way
to improve air quality, reduce congestion and commuting times, shift travel from vehicles to public
transit and other active transport modes, and improve access to transportation. These policies will likely
achieve their intended goals along and near the targeted roads, for example, but it remains unclear
whether there will be unintended consequences such as displacing emissions, air quality impacts, and
adverse health outcomes outside of the regulated zone. The primary objective of this study is to
quantify the health implications associated with road pricing schemes under consideration in the
Washington, District of Columbia, area. Our aims are to: (1) Identify road pricing strategies to achieve
traffic, air quality, and health benefits in the District by leveraging community collaborator input; (2)
Quantify neighborhood-level NO2, PM2.5, and O3 exposure and health effect changes from road pricing
through the development of a novel model framework integrating fine-scale transportation modeling,
air quality modeling, and population health data; and (3) Assess the heterogeneity in air quality and
health implications of the proposed road pricing strategies by comparing NO2, PM2.5, and O3 exposure
and attributable morbidity and mortality for different population subgroups and geographic areas. This
study will quantify traffic, air quality, and health benefits anticipated from road pricing in the District.
The primary significance of this project over existing literature is estimating health benefits of proposed
road pricing schemes using fine scale, state-of-the-science transportation, air quality, and health
outcomes models. This significance builds directly from the REACH Center theme of using big data to
explore health-protective solutions for climate-sensitive risk factors, by leveraging the power of novel
geospatial datasets and research co-generation with governmental and non-governmental partners.
Critically, we have developed the research plan through community and scientific collaborations, and
the results will enable future efforts to quantify health implications of proposed policies in the District.
Our work will provide a framework to employ fine-scale transportation, air quality, and population data
to assess transportation policy schemes seeking to achieve traffic, air quality, and health benefits.